CIRCADIAN RHYTHM OF VASOPRESSIN AND ITS REGULATION

An addendum to this protocol has been implemented to determine the effect of Desmopressin Therapy. Specifically, the goal of this project is to determine the mechanism by which treatment with Desmopressin at bedtime prevents nocturnal enuresis in young adults.